CLINICAL PHARMACOLOGY OF ANTIEPILEPTIC DRUGS

Consistent with a possible difference between the mechanisms of action of the compounds, Phenobarbital (PB) depressed LCMRglu by 30-40%, valproci acid (VPA) by 20-25%, carbamazepine (CBZ) and phenytoin (PHT) by only 10-15%. PB interacts with the GABA-benzodiazepine receptor complex while PHT and CBZ appear to affect currents in active sodium channels. Moreover, other studies have shown that GABA agonists reduce glucose metabolism in experimental animals. Endogenous opiates have been implicated in the pathophysiology of epilepsy. 18F cyclofoxy, a naltrexone analogue, was used to image mu and kappa opiate receptors in patients with complex partial seizures. We found, in a few of the patients, increased opiate ligand binding ipsilateral to the epileptic focus, but no difference in the group as a whole. It is possible that reciprocal changes in Mu and Kappa receptors may obscure the true differences, and studies with more selective tracers are planned. We have been evaluating the effect of drug withdrawal on seizure frequency, in order to assess the presence or absence of transient exacerbations which could be distinguished from a simple loss of drug effect. This was clearly present in the case of PB and CBZ, but absent for PHT. For CBZ, rate of discontinuation was significantly related to seizure frequency. Neuropsychiatric disorders such as panic were increased during drug withdrawal. These data are important for clinical practice. A physician wishing to withdraw a drug known to cause a transient exacerbation during taper may be more likely to persevere when seizures increase. We have been conducting two double blind placebo controlled trials of felbamate, an experimental antiepileptic drug, in patients with complex partial seizures and the Lennox-Gastaut syndrome, a severe childhood epileptic encephalopathy. Patients are entered into the complex partial seizure trial after they have been tapered off their other drugs for surgical monitoring. This process simplifies data collection and clinical screening for several potential trials.